RACIAL DIFFERENCES IN ACE ACTIVITY

We plan to determine whether African Americans have inreased ACE activity - as measured by the pressor and renal vasoconstrictor responses to angiotensin I and angiotensin II compared to those in Caucasins.